Administrative Core

The Florida-California Cancer Research, Education & Engagement (CaRE2) Health Center is a partnership among the University of Florida (UF), Florida A&M University (FAMU) and University of Southern California (USC) to reduce the cancer burden in Florida, California and nationally. Building on the strong foundation and Center accomplishments that met or exceeded the benchmarks set for the first 5-year funding cycle, we propose another 5 years of support for our cutting-edge work. The Administrative Core of the CaRE2 Center will serve as the hub of the CaRE2 Center’s activities, including the management, coordination, supervision and promotion of the Center’s activities. The administrative leadership will be primarily responsible for the Center’s strategic planning, including: defining and upholding its mission and objectives, conducting environmental scanning for strategy development, directing and managing strategy implementation, and ensuring adjustments are made for continuous quality improvement (CQI) based on program evaluation. The established benchmarks for the success of the Administrative Core are: (1) Integrated research efforts focused on drivers of cancer morbidity and mortality by a minimum of 12 UF-FAMU-USC collaborative teams. Three research projects are submitted as part of this application and we anticipate making three additional awards between Years 2 and 4 and six projects supported with a Developmental Research Program and leverage funds, with additional extramural projects anticipated; (2) Integrated research education efforts focused on increasing the pool of cancer research trainees and early-stage investigators focused on reducing cancer burden; (3) Integrated community outreach efforts focused on engaging communities that are susceptible to high cancer incidence and mortality to collaborate on cancer research that reflects mutual interests; (4) Successful dissemination efforts via the Center’s websites, publications, webinars, conference presentations, community outreach events, and educational activities; and (5) Submission of NIH K-series, T-series, and R-series grants led or co-led by a FAMU investigator and led by early-stage investigators.